JEOL 2100PLUS(CR)

Project Summary/Abstract
Cryogenic Transmission Electron Microscopy (cryoTEM) has emerged as a powerful
approach to acquiring structural information from proteins, subcellular organelles, and other
biomacromolecules and their assemblies. This proposal seeks funding to bring cryoTEM
capabilities to the University of Georgia for the purpose of facilitating NIH-supported
research related to cell organelle biogenesis, the biochemistry of metabolism and gene
expression, the mechanisms of diverse human diseases and disorders, antibody
therapeutics, antivirals, treatments for infectious diseases, and fundamental structural and
cellular biology. The proposed equipment includes a cryo-capable, 200 kV transmission
electron microscope (JEOL 2100PLUS) with a direct electron detection device (Direct
Electron DE16ER camera) and the essential equipment needed for sample vitrification and
handling (a Leica EM GP2 automatic plunge freezer, and a Gatan Elsa cryo sample holder
with turbo benchtop pumping station). This multipurpose cryoTEM system will support the
needs of NIH-funded investigators at the University of Georgia (UGA) for (1) the preparation
and screening of vitrified samples; (2) data collection for single particle analysis,
tomographic reconstructions, and micro-electron diffraction; and (3) improved conventional
TEM imaging. This equipment will be installed at the Georgia Electron Microscopy (GEM)
core facility in custom-designed laboratory space, and it will be operated and maintained by
GEM’s staff. By establishing campus-level access to cryoTEM instrumentation, services,
expertise, and hands-on training, this project will enable numerous biomedical researchers to
incorporate cryoTEM methods into their research programs. UGA’s vibrant, NIH-supported
research groups include five major users of cryoTEM, eight minor users of cryoTEM, and
additional investigators who will be future cryoTEM practitioners.

Public health relevance
Project Narrative Cryo-transmission electron microscopy has emerged as a powerful technique for acquiring key structural information from proteins, subcellular organelles, and other biomacromolecules and their assemblies. This proposal seeks funding to bring cryo-electron microscopy capabilities to the University of Georgia for the purpose of facilitating NIH-supported research progress by producing new knowledge related to cell organelle biogenesis, the biochemistry of metabolism and gene expression, and the mechanisms of diverse human diseases and disorders. These projects have strong relationships to public health priorities, specifically by developing targets relevant to respiratory diseases (e.g., RSV, hMPV, influenza), infectious diseases (e.g., malaria, H. pylori), and neurodegenerative processes (e.g., Parkinson’s and Alzheimer’s diseases) through structure-based drug and vaccine candidate design.